Identification of Differences in Verb Learning between Late Talkers and Typically Developing Children

PROJECT SUMMARY
Absent known deficits such as hearing loss or developmental disorder, approximately 15% of two-year-olds
nevertheless have atypically small expressive vocabularies. These “late talkers” (LTs) are at increased risk for a later
diagnosis of language disorder, and even those LTs who are not diagnosed still have poorer long-term language outcomes
as compared to their typically developing peers (TDs). At present, we do not know why some children struggle to develop
their vocabularies, and we are unable to predict which LTs are at greatest risk for language disorder.
This project focuses on toddlers’ verb vocabularies because of the role that verbs play in developing grammar.
Difficulty with verbs is considered a warning sign for later language disorder, and children with language disorder in turn
struggle particularly with verbs. To learn new verbs, toddlers use information derived from the surrounding linguistic
context, such as sentence structure. However, this ability is predicated on preexisting knowledge of verbs. Concerningly,
our prior research indicates that LTs and TDs differ in early verb knowledge: LTs have more result verbs (i.e., verbs that
denote the result of an event, such as “break”) than manner verbs (i.e., verbs that denote how an event unfolds, such as
“run”) in their vocabularies. This pattern mimics biases for result over manner meanings observed in older children with
language disorder. However, TDs have more manner than result verbs throughout development. In contexts where verb
learning is dependent on knowledge of manner versus result meanings, LTs and TDs are likely to perform differently.
In Aim 1/Study 1, we consider one such manipulation: Whether the sequencing of the linguistic information (i.e.,
the verb) and its referent action impacts verb learning. TDs appear to learn manner verbs best when the verb precedes the
action, but they learn result verbs best when the verb follows the action. However, older children with language disorder
better learn verbs when they follow the action, irrespective of verb meaning. We hypothesize that LTs will show the same
pattern as older children with language disorder because they also have a bias for result over manner verbs. If true, this
would be the first demonstrated verb learning difference between LTs and TDs.
Learning a verb’s meaning from its linguistic context also requires that children be able to process the given
linguistic information. Conversely, children who do not process the linguistic context fail to learn new verb meanings. It
has been hypothesized that children who are faster linguistic processors are better verb learners, but this has not yet been
demonstrated experimentally. In Aim 2/Study 2, we consider the relationship between concurrent processing of familiar
words and performance on a verb-learning task (i.e., Study 1). We hypothesize that for both LTs and TDs, those who are
faster to process familiar words will also be better at verb learning.
The final sample will include 52 toddlers (26 LTs; 26 TDs, ages 24.0 – 30.9 months) who will complete both
studies. Data will be collected using eye tracking, and regression analyses will be used to test our hypotheses. Results
from Aim 1/Study 1 will support future research on verb-learning interventions for LTs. Results from Aim 2/Study 2 will
provide the basis for future longitudinal studies aimed at predicting outcomes for LTs.

Public health relevance
PROJECT NARRATIVE Approximately 15% of two-year-olds are “late talkers,” who have smaller vocabularies and learn different types of words as compared to typically developing peers, contributing to an increased risk for a language disorder. Because of the important role that verbs play in language development, this project explores whether differences exist between late talkers and their peers in how they learn new verbs and whether language processing abilities might predict success in verb-learning tasks. Results from this study will provide insight into how late talker language development differs from typical development and will support further research into interventions for those at greatest risk for language disorder.